A simple device for office evaluation of tubal patency during the workup for infertility.

PROJECT SUMMARY
OryGyn Medical Devices, LLC is developing a novel and highly innovative Tubal Selective Delivery System
(TSDS) designed to safely and selectively administer fluids, foams, or gels to the fallopian tubes through a
nonsurgical transcervical approach. The basic work-up of infertility includes evaluation of whether the tubes are
open to passage of eggs and sperm (fallopian tube patency) using a hysterosalpingogram, a radiologic study
that requires referral to a specialist and exposure to ionizing radiation. The TSDS would provide clinicians with
a simple and convenient office-based option for evaluation of tubal occlusion without referral to specialists. The
worldwide prevalence of infertility, defined as failure to conceive after more than 12 months of unprotected
intercourse, is approximately 8%–12% and decreased ability to conceive - subfertility - affects an additional
15% of couples. The TSDS would increase convenience for patients and decrease costs associated with
evaluation of this problem. In this Phase I proposal, we propose the following objectives: Aim 1: Compare
characteristics of internal and external frame designs to identify and manufacture a second generation FertChx
TSDS; Aim 2: Demonstrate the performance characteristics of FertChx using a simulated uterine model to
establish benchmarks for a clinical testing. This Phase I project will characterize the performance of a lead
device and provide documentation of the good manufacturing practices (GMP) required for production of
devices for a clinical trial. Successful completion of Phase I will support submission of a Phase II proposal to
complete a clinical trial evaluating safety and efficacy of the device for verification of tubal patency and
necessary components for regulatory review. Together, the Phase I and II programs will support our business
objective of 510(K) approval of the lead TSDS device for use as an office-based device for tubal patency
evaluation.

Public health relevance
PROJECT NARRATIVE The gold standard procedure for evaluation of tubal patency in women suffering with infertility is the hysterosalpingogram (HSG), a radiologic study that requires referral to a specialist and specialized equipment, exposes women to ionizing radiation, and is often available only in urban areas, which means many women of reproductive age do not have access to it. To streamline this initial diagnostic step in the infertility workup, OryGyn Medical Devices, LLC is developing a medical device, the Tubal Selective Delivery System (TSDS), which provides a simple and convenient office-based evaluation of obstructed fallopian tubes that does not require imaging or referral to a specialist. Use of the TSDS would increase convenience for patients and decrease cost of the initial steps of evaluating infertility.